Improving functional MRI Analysis via Integrated One-Step Tensor-variate Methodology

Project Summary
This proposal will deliver an innovative integrated statistical approach to analyze functional Magnetic Resonance Imaging
(fMRI) data. The massive size of fMRI data has dictated, to date, a two-stage analysis, ﬁrst reducing the temporal data at
each voxel to a single activation value, followed by a spatial analysis for activated regions. Our basic premise is that an
integrated one-stage, whole-brain data strategy will improve estimation and power even in studies with small sample sizes.
The proposed methods will be generally applicable to fMRI data, but to illustrate the value of the methods, we will
reanalyze publicly available datasets from two areas of importance to mental health. Suicide is a major public health concern,
with the CDC reporting it to be the cause of two-thirds of all homicides in 2017, yet it remains highly unpredictable. Recent
work provided fMRI data on 34 subjects upon exposing them to 10 words each with positive, negative or death-related
connotations. Analysis of such involuntary data can reveal differences between suicide attempters and ideators, pinpoint
subjects with elevated suicide risk, or identify the words with highest discriminatory power between groups, all useful outcomes
for diagnosing and preventing suicide. Major Depressive Disorder (MDD) is projected to be the most prevalent cause of
disease worldwide by 2030, yet only half of MDD patients receive treatment. A recent study provided fMRI data on 39
subjects using a validated emotional musical and nonmusical auditory paradigm. The long-term goal is to leverage music as
a diagnostic or therapy for MDD. We will use our methods to re-evaluate sex, age, and other measured covariates, such
as subject ratings of the music, which were previously only analyzed descriptively, to better detect differences in cerebral
activation between MDD and controls, including one MDD subject with missing data due to excess motion in the machine.
Our approach will directly model the complex, high-dimensional structure of fMRI data, including three spatial dimensions,
time, and subject, by extending multivariate linear regression to a more natural and correct tensor-on-tensor linear regression
framework, previously assumed to be computationally intractable. Our work will make it feasible and if the power advantages
are as substantial as we expect, our approach should become the standard for fMRI data analysis in the future. The linear
regression framework is familiar to practictioners, which along with the efﬁcient, user-friendly software we will develop, will
facilitate its wide adoption in the fMRI community.
We develop tensor-on-tensor time series regression in Aim 1 and associated methods to classify patients and identify
biomarkers in Aim 2. Application of our methods to a suicide and MDD datasets will serve to demonstrate the methods, while
revealing actionable information about these two very important mental health challenges. More broadly, increased reliability
and reproducibility with fewer subjects and shorter tasks will decrease the cost, time, and discomfort of future fMRI studies,
and could encourage the adoption of fMRI in a clinical setting where pathology detection can be followed by diagnosis and
appropriate intervention. Finally, the ﬂexible statistical framework we provide will encourage further modeling innovation to
accommodate challenges in and hypotheses about the structure of fMRI data, including those not yet imagine.

Public health relevance
Narrative The proposal will develop an innovative integrated but computationally practical one-step statistical approach to analyze functional Magnetic Resonance Imaging (fMRI) data to improve the consistency and stability of detected activation differences between groups of subjects, to accurately predict disorder or disease status or to identify biomarkers related to the conditions being studied. Our integrated holistic approach will improve estimation and allow for valid inferences even in group studies with small sample sizes. We will illustrate and use our developed methods to reanalyze two publicly available datasets of suicide and major depressive disorder which are areas of great public health concern in the United States and the world.